Alcohol and mesolimbic glutamatergic transmissions

DESCRIPTION (provided by applicant): Alcoholism in the United States is a serious health concern. Our long-term goal is to elucidate the mechanisms underlying alcohol addiction, a necessary prerequisite to the development of effective therapy. The specific hypothesis is that acute ethanol increases glutamate release via activation of dopamine D1 receptors (D1R). The increased glutamatergic transmission in turn modulates dopaminergic cell activity in the reward pathway and thus plays a significant role in the processes involved in alcohol addiction. We base this hypothesis on the following observations: a) clinically relevant concentrations of ethanol (10-80 mM) increase the amplitude of evoked excitatory postsynaptic currents (EPSCs) mediated by AMPA receptors. In addition, ethanol reduces paired-pulse facilitation of evoked EPSCs and increased the frequency but not the amplitude of spontaneous EPSCs. Furthermore, ethanol increases extracellular glutamate levels in the ventral tegmental area (VTA) in midbrain slices and in vivo in rats;and b) the effects of ethanol are mimicked by a D1R agonist or a dopamine reuptake inhibitor, and they are blocked by a D1R antagonist or by depleting dopamine stores with reserpine. This hypothesis will be tested in the VTA of rats or mice by a combination of electrophysiological and pharmacological techniques. This includes measurements of extracellular glutamate and dopamine levels in both the VTA and the nucleus accumbens, in brain slices and/or in vivo. The Specific Aims are to determine: 1) The effects of ethanol on glutamatergic transmission to VTA dopamine neurons. We will compare AMPA receptor-mediated EPSCs and extracellular glutamate and dopamine levels in the absence and presence of ethanol. 2) The role of presynaptic D1Rs in the ethanol-induced increase in glutamatergic transmission to VTA dopamine neurons. We will compare the effects of ethanol on EPSCs and on extracellular glutamate levels in the absence and presence of a D1R agonist or antagonist. 3) The functional consequences of ethanol-mediated facilitation of glutamate release on the output of VTA dopamine neurons. We will determine whether glutamate antagonists: 1) attenuate the effects of ethanol on the excitability of VTA DA neurons, and 2) block the ability of systemic ethanol to increase dopamine release in the nucleus accumbens when the antagonists are infused into the VTA.

Public health relevance
PUBLIC HEALTH RELEVANCE The results of these studies will clarify a novel mechanism that is a significant component of the action of ethanol on the brain`s reward pathways. A better understanding of cellular mechanisms of alcohol addiction will improve the treatment and prevention of alcoholism. __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): A. SPECIFIC AIMS The mechanisms underlying alcohol addiction are not well understood. Despite much evidence linking the dopaminergic (DA) neurons of the ventral tegmental area (VTA) to ethanol (EtOH), the specific mechanisms through which EtOH enhances VTA DA cell excitability are not totally clear. One of our long-term goals is to elucidate the molecular, cellular and synaptic mechanisms underlying alcohol addiction. Glutamatergic (GLUergic) inputs to VTA DA neurons provide the major excitatory control of VTA activity and ultimately of dopamine release in the reward pathway. Dopamine receptors, in particular the D1 receptors (D1Rs) situated on GLUergic axons afferent to DA neurons in the VTA, could be a locus for facilitating GLUergic synaptic transmission. Since glutamate is important in the mechanism of addiction, this facilitation may further the development of alcohol addiction. The objective of this proposal is to study the acute effects of EtOH on GLUergic transmission and their impact on the excitability of VTA DA neurons, a necessary first step towards our long-term goal. In several areas of the brain, acute EtOH depresses glutamate-mediated excitatory transmission, but the effect of EtOH on excitatory synapses on DA neurons of the VTA remains unknown. Our preliminary data show a) that clinically relevant concentrations of EtOH (10-80 mM) increase the amplitude of evoked excitatory postsynaptic currents (EPSCs) mediated by AMPA receptors. In addition, EtOH reduces paired-pulse facilitation of evoked EPSCs and increases the frequency but not the amplitude of spontaneous EPSCs. Furthermore, EtOH increases extracellular glutamate levels in the VTA in midbrain slices and in vivo in rats; and b) that the effects of EtOH are mimicked by a dopamine D1R agonist or a dopamine reuptake inhibitor, and they are blocked by a D1R antagonist or by depleting dopamine stores with reserpine (see preliminary data section for details). Based on these unexpected findings and the literature, we hypothesize that acute EtOH increases glutamate release via activation of D1Rs. The increased GLUergic transmission in turn modulates DA cell activity and output, and this could play a significant role in the processes involved in alcohol addiction. This hypothesis will be tested in the VTA of rats or mice by a combination of electrophysiological and pharmacological techniques. These include the measurements of extracellular glutamate and dopamine levels in both the VTA and the nucleus accumbens (NAcc), in brain slices and/or in vivo (in collaboration with Dr. Shao at UCLA and Dr. Olive at MUSC). We therefore propose studies with the following Specific Aims: 1) To determine EtOH's effects on GLUergic transmission to VTA DA neurons. We will compare AMPA receptor-mediated EPSCs and extracellular glutamate and dopamine levels in the absence and presence of EtOH. We expect that EtOH will enhance EPSCs and extracellular levels of glutamate and dopamine. 2) To determine the role of presynaptic D1Rs in EtOH-induced increase in GLUergic transmission to VTA DA neurons. We will compare the effects of EtOH on EPSCs and on extracellular glutamate levels in the absence and presence of a D1R agonist or antagonist. We expect that the D1R agonist and EtOH will enhance GLUergic transmission and extracellular glutamate levels. Furthermore, the EtOH-induced enhancement will be prevented by a D1R antagonist. 3) To assess the functional consequences of EtOH-mediated facilitation of glutamate release on the output of VTA DA neurons. We will determine whether glutamate antagonists: 1) attenuate the effects of EtOH on the excitability of VTA DA neurons, and 2) block the ability of systemic EtOH to increase dopamine release in NAcc when the antagonists are infused into VTA. The proposed work is innovative as a multidisciplinary approach that includes electrophysiology, pharmacology, neurochemistry, immunocytochemistry and molecular genetics on three different preparations to investigate a previously unrecognized effect of EtOH on GLUergic transmission in the VTA. The results of these studies will clarify a novel mechanism that is a significant component of the action of EtOH on the brain`s reward pathways. A better understanding of cellular mechanisms of alcohol addiction will improve the treatment and prevention of alcoholism. To help the reviewers put this hypothesis into perspective, the following scheme illustrates how presynaptic D1Rs and EtOH are proposed to influence GLUergic transmission, extracellular glutamate levels, and cell excitability. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page Principal Investigator/Program Director (Last, First, Middle): Fig. 1. Simplified diagram shows the major targets in this project. Aim 1 will study EtOH effects on GLUergic transmission to VTA DA neurons. Aim 2 will study the role of presynaptic D1Rs on EtOH-induced enhancement of GLUergic transmission. Aim 3 will study the functional consequences of EtOH-induced increase of glutamate release in VTA. This project focuses on the somatodendritic release of dopamine and the D1Rs on GLUergic axons forming synapses on VTA DA cells. Note that the extrinsic DA projection to VTA is negligible [1]. Thus, the only important source of dopamine in VTA is somatodendritic release. D1Rs are located on the glutamate-releasing afferent to the VTA DA neuron, but not on the DA neurons. CONCEPTUAL FRAMEWORK EtOH could act by increasing a dopamine-mediated facilitation of GLUergic inputs onto DA cells by one (or some combination) of the following four mechanisms: 1) directly potentiates somatodendritic dopamine release in the VTA if EtOH directly excites DA neurons [19]; 2) raises extracellular dopamine levels by blocking dopamine reuptake (but see [168]; 3) sensitizes D1Rs on GLUergic axons to dopamine; and 4) directly modulates D1R signaling [122,123]. In addition, EtOH could disinhibit the VTA DA neurons by reducing glutamate release onto GABAergic interneurons [142]. The EtOH- induced facilitation of DA cell firing may be partly counteracted by EtOH-induced inhibition of postsynaptic NMDA receptors (situated on DA cells) and by the activation of D2Rs on the GLUergic terminals and on the DA cells. Note that ambient dopamine levels are much lower in VTA than in the NAcc, and that in the prefrontal cortex, D2Rs are relatively insensitive to dopamine, compared to D1Rs [3,149]. Furthermore, D2Rs in the VTA are less sensitive to dopamine, as implied by a study showing that somatodendritic release in VTA is not under significant D2R control [34]. Thus, presynaptic D1Rs are likely to be the predominant target for dopamine released by EtOH in the VTA. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page